Development and molecular phenotypes of zebrafish astrocytes

Astrocytes are the major glial cell type in the human brain and are critical for central nervous system (CNS) development and function. Astrocyte dysfunction has been implicated in human neurodevelopmental and psychiatric diseases. Given the important roles astrocytes play in CNS development and health, it is surprising that little is known about the molecular and cellular mechanisms that govern astrocyte maturation and their functional interactions with neighboring cells. One caveat for currently available model systems is the inability to manipulate and observe astrocyte development and dynamic changes in living, intact animals. Transparent zebrafish larvae would be ideally suited for such studies, but bone fide astrocytes have not been described in this system to date. Here, we aim to exploit the optical transparency of zebrafish larvae together with molecular and genetic approaches to characterize a new glial cell type in zebrafish that features key hallmarks of mammalian astrocytes. We have identified a previously unreported cell type in zebrafish CNS with several defining characteristics of mammalian astrocytes, such as intricate bushy morphology, glutamate transporter expression, and spontaneous microdomain Ca2+ transients. In this proposal, we will: 1) fully characterize the development and function of astrocytes in zebrafish; 2) develop a cell-specific CRISPR/Cas9 method to study astrocyte biology in vivo. We expect our work will establish zebrafish as a new model system to explore astrocyte development and function, provide new insights into the molecular and cellular mechanisms regulating astrocyte development and growth, and lay the foundation to study astrocyte function in the context of the entire nervous system in an intact and behaving animal.

Public health relevance
Emerging evidence suggests astrocytes are essential for brain development and function; however, lack of knowledge about how astrocytes are specified and interact with surrounding neurons and other glial cells in the CNS inhibits understanding their role in neurological diseases. Here, we propose to establish zebrafish as a new vertebrate model system to study astrocyte biology. Our work represents an exciting fundamental step toward dissecting functional interactions of astrocytes with neighboring cells in the brain and can provide critical insights into our understanding of astrocyte development and dysfunction in humans.